Anabolic Versus Catabolic Skeletal Effects of Endurance or Resistance Exercise in Older Veterans

Exercise is frequently recommended to reduce the risk of osteoporotic fracture. However, bone does not
always result in the expected improvements in bone mass, and there is evidence that endurance exercise may
lead to bone loss under certain conditions. It is our contention that disruptions in calcium homeostasis during
exercise, resulting in a decrease in serum ionized calcium (iCa) and increases in parathyroid hormone (PTH)
and c-telopeptide of type I collagen (CTX; a marker of bone resorption) that occur shortly after the start of
exercise, may be responsible for the lack of the expected improvements in bone mineral density. The iCa,
PTH, and CTX responses to exercise have been well-characterized for both young and older adults in
response to a single endurance exercise bout, but it is unclear if resistance training (e.g., weightlifting) results
in the same exercise-induced disruption in calcium homeostasis. Further, it is unclear how the iCa, PTH, and
CTX response to exercise may change with exercise training, and if a bone anabolic response to exercise can
be detected after repeat exercise bouts. The bone anabolic response to exercise (assessed by procollagen of
type I terminal propeptide, P1NP; a marker of bone formation) has yet to be fully characterized, but that may
be due to the testing of single exercise bouts and the short sampling timeline following exercise. To address
these gaps in knowledge, up to 60 Veterans (30 men, 30 women), aged 60-80 years, will be randomized to 1)
stationary cycling; or 2) resistance training and will complete 10 weeks of supervised exercise training 3x/week
(30 total exercise training sessions). This number of exercise visits was due to the demonstrated increase in
P1NP after 28 doses of teriparatide, a PTH analog, that results in bone formation. During the 1st, 15th, and 30th
exercise training session, participants will undergo an acute exercise testing bout with pre- and post-exercise
sampling up to 48 hours after exercise. Blood samples will be collected to measure iCa, PTH, CTX and P1NP.
The primary aims are 1) to determine if resistance exercise results in a different bone biomarker response
compared to what we have observed during endurance exercise in older adults; 2) determine if resistance
and/or endurance exercise result in an increase in P1NP over 10 weeks of exercise training. Exploratory
outcomes related to changes in fitness and functional status will address how Veteran health is impacted by
each exercise type, which will be used to inform future applications. The biomarker and functional outcomes
information are the next step in determining the appropriate “dose” of exercise, consisting of factors such as
exercise type, frequency, duration, and intensity (which will be explored in future research), can be used to
enhance Veteran health. Exercise should continue to be recommended for overall health, but future
interventions could incorporate what is known about the dose of exercise that is needed for cardiometabolic
health and the emerging data on the dose of exercise needed to preserve bone health to create personalized
exercise prescriptions to improve multiple components of Veteran health. The proposed research is significant
because it is investigating several knowledge gaps that need to be addressed to design future, larger exercise
and lifestyle interventions aimed at preserving multiple components of Veteran health, which could have a
lasting impact on Veteran quality of life and functional independence. The proposed research is innovative
because it is testing novel hypotheses, the mode of exercise on the disruption in calcium homeostasis and the
role of exercise training, in a population that could greatly benefit from the knowledge to be gained. Long-term,
information gleaned from this research will help to define personalized exercise prescriptions to improve
cardiometabolic health without compromising bone health in aging Veterans.

Public health relevance
The decrease in serum ionized calcium and the increase in parathyroid hormone and c-telopeptide of type I collagen (a marker of bone formation) that occurs during exercise, referred to as a disruption in calcium homeostasis, may explain why bone does not always result in the expected exercise-induced increase in bone mass or why exercise may lead to bone loss under certain conditions. The disruption in calcium homeostasis has been well-characterized for acute endurance exercise, but the effects of resistance exercise and exercise training are less clear. The purpose of this study is to determine if resistance exercise results in a different bone biomarker response compared to endurance exercise, and if the disruption in calcium homeostasis is impacted by 10 weeks of endurance or resistance training. Blood samples will be collected before, during, and after the exercise training period for assessment of changes in markers of bone resorption and formation. Data will be used to develop future exercise interventions in older Veterans aimed at preserving bone health.